STRUCTURE &FUNCTION OF FLAVIN CONTAINING ENZYMES

Current proposal has three main projects, the first is a de Novo structure determination and the other two projects are to obtain higher resolution data sets to study detailed mechanism of enzyme catalysis and/or inhibition. Data collection was done on BioCARS Station 14-BM-D.